Non-Cigarette Tobacco Products as Harm Reduction Tools in Smokers Who Failed to Quit With Traditional Methods

Abstract
The majority of smokers try to quit each year, and the majority of quit attempts fail, even when the most effective
FDA-approved pharmacotherapies are used. Non-combustible tobacco products emit fewer harmful chemicals
than cigarettes, and thus for smokers who cannot quit smoking, switching completely to a less harmful product
is likely to improve their health. For smokers who have failed to quit with traditional methods, trying to switch to
a less harmful product may be more likely to help them stop smoking than trying to quit using tobacco altogether
repeatedly with pharmacotherapy. The proposed trial evaluates the potential of non-cigarette tobacco products
to serve as harm reduction tools for current smokers who have already tried, and failed, to quit with traditional
methods. Current smokers who failed to quit with FDA-approved pharmacotherapy within the past year (N=225)
will be randomly assigned to either 1) switch completely to a non-cigarette tobacco product (Switch Group,
n=150), or 2) try to quit again using pharmacotherapy (Meds Group, n=75). Participants will choose among a
limited menu of products or medications they would like to receive (maximizing external validity) and select a
Target Switch / Quit Date on which they will stop smoking. Participants in the Switch Group will choose between
two non-cigarette products that deliver sufficient nicotine and are appealing to adult smokers: e-cigarettes, the
most commonly used non-cigarette tobacco product, or heated tobacco products, a novel tobacco product
recently approved for sale by FDA as modified risk exposure compared to cigarettes. Both product classes, while
not safe, emit fewer harmful chemicals compared to cigarettes. Participants in the Meds Group will choose
between the two most effective pharmacotherapies available: varenicline or combination transdermal nicotine
replacement therapy and short-acting nicotine lozenge. Participants in the Switch or Meds groups will receive a
9-week supply; broken down as: 1-week to use ad libitum while continuing to smoke, and 8-weeks to use as
instructed following a Target Switch or Quit Date. The primary outcome is biochemically-confirmed abstinence
from cigarette smoking at the 6-month follow-up, and secondary outcomes include smoking reduction > 50%,
longest quit attempt duration, biomarkers of nicotine, smoke, and toxicant exposure, and changes in respiratory
symptoms. The proposed trial addresses a highly significant research question using a rigorous design and is
supported by a strong investigative team. The trial is in line with priorities within NOT-OD-22-023 including “Harm
reduction studies that involve switching from combustible cigarettes to ENDS [or heated tobacco products].”

Public health relevance
Project Narrative Non-cigarette tobacco products have the potential to reduce harm for smokers who want to quit but cannot. The proposed trial will evaluate whether e-cigarettes and heated tobacco product are able to promote abstinence from smoking compared to FDA-approved pharmacotherapy for smoking cessation. The results of the proposed trial will provide information about whether these products have utility for reducing harm among adult smokers who cannot quit smoking.